Mechanisms of chromatin regulation of transcription

MECHANISMS OF CHROMATIN REGULATION OF TRANSCRIPTION
PROJECT SUMMARY
Over the past decade, the Poirier lab has worked to contribute to the fields of chromatin biology and
transcription regulation by developing a research program that is focused on the mechanisms by which
chromatin and nucleosome structural dynamics regulate genome accessiblity to transcription regulatory
complexes. We have developed and applied on our own and through collaborations, a wide range of
experimental tools that enable mechanistic studies including single molecule fluorscence, single molecule force
spectroscopy, ensemble fluorescence, and histone chemical ligations. In combination, we have quantitatively
investigated how chromatin regulators including histone post translational modifications (PTMs), PTM binding
proteins (readers), chromatin remodelers, linker histones, and transcripton factors function to control genome
accessiblity to chromatin regulatory complexes. Building off this work, we propose to investigate two central
questions in the fields of chromatin biology and transcription in the coming 5 years: (i) How do pioneer
transcription factors target their recognition sites within compact nucleosomes and chromatin, and then
facilitate chromatin decompaction? (ii) How do epigenetic regulators function together to synergistically or
antagonistically regulate genome accessibility to transcription regulatory complexes?
Pioneer factors (PFs) are master regulators of cell differentiation, are correlated with nucleosome depletion,
and somehow access their binding sites within compact chromatin that are inaccessible to canonical
transcription factors (TFs). Furthermore, PF disfunction is strongly correlated with disease most notably
cancer. By combining single molecule and ensemble studies we will directly test distinct mechanisms of PF
function, and determine what differentiates PFs from canonical TFs. Furthermore, through collaborative work
we will investigate the same PFs in vivo to determine how the PF mechanisms that emerge from our in vitro
studies impact their functions in vivo. This first direction will provide key insights into how pioneer factors gain
access to their sites within compact chromatin and what differentiates PFs from canonical TFs.
Epigenetic regulators including histone PTMs, and their readers and writers are critical to organismal
development, aging and numerous diseases including cancer. We and others have investigated these
regulators individually, yet how they function in combination remains largely unknown. Leveraging our ability to
prepare core histone and most recently linker histones with any combination of PTMs, histone H3 readers, and
most recently biochemical quantities of endogenous human SAGA and ATAC complexes, we will use single
molecule, ensemble and ES cell-based methods to determine how biologically relevant combinations of these
regulators control accessibility to canonical TFs and influence PFs. This second direction will provide a
mechanistic and functional foundation for understanding how key epigenetic transcriptional regulators
differentially control chromatin dynamics, accessibility and transcription.

Public health relevance
PROJECT NARRATIVE Regulation of gene expression and cell differentiation by pioneer transcription factors and epigenetic factors is a major focus in cancer epigenetics because of the master regulator function of pioneer factors and the reversible nature of epigenetic alterations. Recent advances in understanding epigenetic factors have led to the emergence of epigenetic therapy and the recent FDA approval of multiple epigenetic drugs. This proposal uses a combination of in vitro biochemical, biophysical and single molecule methods, combined with in vivo genetic and cell biology approaches to reveal the molecular mechanisms behind the function of pioneer factors and these chromatin epigenetic regulators. Our studies will provide molecular information for understanding drug resistance, tumorigenesis and will help designing new drugs and therapies.